Columbia Population Research Center - Development Core

Development Core – Abstract
The development core (DC), led by Matthew Neidell (Health Policy & Management, School of Public Health),
Neeraj Kaushal (Social Work), Yao Lu (Sociology, Arts & Sciences), and, new with this renewal, Heidi Allen
(Social Work), increases the scientific impact, innovation, and productivity of CPRC’s population dynamics
researchers, increases their competitiveness for peer-reviewed external funding, supports the professional
development of junior scientists, and advances CPRC’s center-wide aims. The DC accomplishes this by
designing, implementing, and monitoring a comprehensive set of services and activities, including: 1) the seminar
series; 2) five primary research areas (PRAs); 3) a cross-cutting theme; 4) working groups; 5) a seed grant
program; 6) junior scientist mentoring and support; 7) pre- and post-award grant support, substantially enhanced
in this renewal application; and 8) a new partnership to share resources and foster collaborations with population
dynamics researchers at the City University of New York (CUNY), a local public university that does not have a
P2C-funded center.